Administrative Core

The Partnership for Native American Cancer Prevention (NACP) is an ongoing 21-year old collaboration
between Northern Arizona University (NAU), an institution serving underserved heath disparity populations and
underrepresented students (ISUPS), and the University of Arizona Cancer Center (UACC), a National Cancer
Institute-Designated Comprehensive Cancer Center. NACP will focus on health equity as Native American
teachings speak to a positive path for creating a healthy future. The overarching goals and objectives of the
NACP are to reduce the cancer burden within the Arizona Native American population through
research and community engagement; expand the number of Native American investigators working in
cancer research; and increase the total number of investigators focused on Native American cancer
health equity.
The NACP Administrative Core is the essential central component of NACP that brings together the inter-
institutional leadership to administer, coordinate and manage the U54 goals and aims. The Administrative Core
ensures alignment, integration, communication, and transparency occurs between the respective Cores,
Shared Resource, and research projects. The Core is responsible for NIH reporting, institutional accountability,
including the interaction with the UACC Office of Community Outreach and Engagement (COE), overall
financial management, tracking of specific aims progress, process Core and project evaluations, and facilitates
the interactions and communications with the three advisory committees: Internal Advisory Committee (IAC),
Program Steering Committee (PSC), and the Community Advisory Board (CAB).
The Administrative Core will also initiate recruitment of Early-Stage Investigators (ESI) focused on cancer
health disparity research that will benefit tribal communities. To ensure the success of NACP’s goals and
objectives outlined throughout this application, the Administrative Core is charged with the following aims:
Aim 1. Engage a Partnership leadership team that integrates all the research projects, Cores, and Shared
Resource activities in support of NACP goals and objectives, with a particular focus on supporting early
stage investigators (ESI).
Aim 2. Provide administrative management for the entire Partnership including facilitating communication
between Cores and research projects, fiscal management of all components, and community dissemination.
Aim 3. Coordinate the participation of the three advisory boards within NACP’s planning and evaluation
activities and interface with NCI CPACHE providing timely reports and responses to request for information.
Aim 4: Collaborate with the UACC Office of Community Outreach and Engagement (COE) to address
cancer health equity throughout the state and the World Indigenous Cancer Conference organizers to
provide an international NACP impact.